Toward parsing gut microbiota-epithelium-immune metabolic crosstalk in Celiac Disease

Project Summary/Abstract
Celiac Disease (CD) is an autoimmune digestive disease triggered by the consumption of gluten-containing
grains (the environmental trigger) in genetically predisposed individuals. The exact cause of CD is unknown as
research shows that genetic predisposition and exposure to gluten are necessary but not sufficient to trigger
the development of CD. A growing body of research supports the critical role of the gut microbiota in CD
pathogenesis as alterations in the gut microbiota composition (“gut dysbiosis”) have been associated with the
clinical manifestation and severity of CD. However, it is unclear whether the gut dysbiosis is the cause or the
consequence of intestinal inflammation in CD. This is because there are critical gaps in our knowledge about
molecular mechanisms and biochemical pathways through which the gut microbiota interacts with the host and
environment, and how precisely specific microbial species/strains contribute to a disrupted gut homeostasis
and the loss of gluten tolerance in CD. This proposal aims to build a mechanistic understanding of the
functional role of individual gut microbes and the gut microbiota as a whole in CD pathogenesis. To this end,
we will leverage multi-omics data and specimens collected before and at disease onset from at-risk subjects to
construct mechanistic in silico and ex vivo models of the gut microbiota and host. Our in silico models are
based on computational genome-scale models of metabolism and integrate diet (as an environmental risk
factor), the gut microbiota (at metagenome scale), and the host’s intestinal epithelial cells and macrophage into
one inclusive model. Our ex vivo models are based on patient-derived organoid co-cultures and integrate the
host’s intestinal epithelial cells and macrophages with microbial cues. By modeling germ-free and non-germ-
free human gut conditions using these in silico and ex vivo models, we aim to address two key objectives. First,
we will uncover specific gut microbial species/strains that are mechanistically linked to the production of
modulatory metabolites previously implicated in CD under different dietary regimens. Second, we will parse the
metabolic crosstalk between the gut microbiota and the host’s intestinal epithelial cells and macrophages
before and at disease onset. This integrative approach will allow us to uncover key microbial players in the gut
that individually or collectively trigger aberrant metabolic and immunometabolic responses by the host in the
early stages of disease development. Overall, this study paves the way for designing early intervention and
therapeutic strategies for CD that target specific gut microbial strains to re-establish the host’s immune and
metabolic homeostasis.

Public health relevance
Project Narrative A mechanistic understanding of how the gut microbiota influences the development and progression of Celiac Disease is currently missing. This project aims to dissect the complex metabolic interactions between the microbiota and the host in Celiac Disease. This will help establish causal relationships between the gut microbiota and the disease, paving the way for the development of therapeutic strategies that target the gut microbiota to treat Celiac Disease